PRIHSM Training Component

Project Summary – Training Component
The goals of the Training Component are to: (1) develop a training program that cultivates a community of
trainees focused on maternal health; (2) build content knowledge and expertise relevant to conducting multi-
disciplinary research in prevention and treatment of postpartum hemorrhage (PPH) and related maternal
morbidities and mortality; and (3) equip clinicians with skills important for the treatment of PPH. These goals
will be accomplished by developing a diverse, multi-disciplinary team of trainees and mentors, implementing
specific activities tailored to meet the needs of trainees with a wide variety of experiences and interests, and
leveraging existing programs within Stanford. Postpartum hemorrhage is the thematic focus of PRIHSM and
will be a unifying thread throughout training activities, which will also extend to the additional focus areas of our
projects: severe maternal morbidity (SMM) and mortality, antepartum anemia, cesarean birth, and postpartum
mental health. We will work with trainees at varied stages of training (e.g., undergraduate to early-stage
investigator) and representing varied disciplines (e.g., clinical medicine, psychology, epidemiology,
implementation science, and community-engaged research), with specific emphasis on recruiting trainees that
qualify as under-represented minorities (URM) per NIH. Training and mentoring opportunities will also be
available to community partners to ensure bi-directional learning and community engagement. Our clinical
training program will focus on regions with limited maternal health care resources. Our Specific Aims are:
Aim 1: Build content knowledge necessary for conducting maternal health research, related to: a) the maternal
health crisis in the U.S.; b) foundations of community-engaged, equity-focused maternal health research; c)
research design and methods; d) logistics of the research process. Trainees will have access to didactics to
cover these topics, and a PRIHSM trainee discussion forum will enhance these learnings and build community.
Aim 2: Enhance and evaluate mentored research experiences conducting rigorous, actionable, equity-focused
maternal health research, by developing personalized plans and mentor teams tailored to the needs and
interests of individual trainees. Trainees will work on specific PRIHSM Research Projects and have
opportunities to work with community partners and other ongoing projects related to maternal health. Aim 3:
Train clinicians in under-resourced settings on best practices for prevention, treatment, and management of
PPH. We will work with Stanford’s GO MOMs program, which provides simulation-based training to optimize
team performance in obstetric emergencies. In sum, through this Training Component, we will increase the
pipeline and diversity of maternal health researchers, build competence in maternal health research and
clinical care, and enhance community partnerships that will all contribute to our stated goals and enhance
PRIHSM’s research projects. Together, accomplishment of these goals will lead toward a future of safety and
equity for all birthing people in the U.S.